A Thermo Q Exactive UHMR Instrument for Native Mass Spectrometry

Proposed here is the purchase of a Q Exactive UHMR quadrupole-Orbitrap mass spectrometer for native mass
spectrometry (nMS) analyses. The primary purpose of this new instrument will be to provide state-of-the-art
mass range, mass resolution and sensitivity for nMS analysis to enhance research programs in microbiology,
immunology, cancer, digestive disease, and vision research. More specifically, the UHMR instrument will be
used to interrogate the structures of native protein complexes, to screen for protein-ligand interactions, to
identify membrane protein-lipid interactions, and to provide spatially-resolved nMS data from tissue samples.
The requested instrument will reside in the Proteomics Core of the Mass Spectrometry Research Center at
Vanderbilt University. The UHMR technology will provide a new capability to the Vanderbilt user group and will
significantly enhance our capabilities in structural biology. Further, it will facilitate the establishment of a nMS
core service that will be supported as a Community Engagement activity by the proposed National Center for
Biomedical Technology Development and Dissemination at Ohio State University. The requested instrument
will support a large number of NIH funded investigators including eight major user projects and seven minor
user projects with ongoing clinical and/or translational protein structure projects. Furthermore, investigators
from the Vanderbilt Institute for Infection, Immunology and Inflammation, the Vanderbilt Diabetes Center, the
Digestive Disease Center, the Vision Research Center, the Vanderbilt Ingram Cancer Center and the
Vanderbilt Center for Structural Biology will benefit from the new capabilities. The instrument will be managed
by the Core Associate Director who will be responsible for instrument oversight and experimental design
planning with users as well as a staff scientist responsible for instrument QA/QC as well as sample preparation
and data acquisition. Operational funds will be generated from the Core’s standard fee schedule as established
by the Vanderbilt Office of Research and as approved by the Core’s oversight committee. In addition, an
instrument advisory panel will be established and consist of major users, a minor user, a non-user proteomics
expert, and a member of the institution’s Core administration.

Public health relevance
Project Narrative The overall goal of this proposal is to provide native mass spectrometry capabilities to the research community at Vanderbilt University who will use the requested instrument to study protein-protein, protein-lipid, and protein-RNA/DNA complexes in microbiology, immunology, cancer, diabetes, digestive disease, and vision research. A large number of investigators will benefit from the enhanced capabilities of the requested Q Exactive UHMR mass spectrometer to structurally characterize protein complexes that are important in human health or diseases.